TAXI-CAB: Transfusion and Anemia eXpert Initiative - Control/Avoidance of Bleeding

PROJECT SUMMARY Plasma and platelet transfusions are frequently prescribed to critically ill children who are actively bleeding or at risk of bleeding. These fragile children may require plasma and/or platelet transfusions given their underlying organ dysfunction, including suppression of bone marrow and/or hepatic insufficiency, medications that may suppress their functional ability to clot, consumption, and frequent invasive procedures. Despite their possible therapeutic benefits, both plasma and platelet transfusions have been independently associated with significant morbidity and mortality in this population. Given the significant dangers, guidelines must be available to help intensivists weigh the risks and benefits to their patients. Current recommendations do not adequately or reliably address clinical scenarios specific to critically ill children. The Transfusion and Anemia eXpert Initiative – Control/Avoidance of Bleeding (TAXI-CAB), in collaboration with the Pediatric Critical Care Blood Research Network (BloodNet), the Pediatric Acute Lung Injury and Sepsis Investigators (PALISI), the Society for the Advancement of Blood Management (SABM), the Network for the Advancement of blood management, Haemostasis and Thrombosis (NATA), the International Society of Blood Transfusions (ISBT) and the Society for Critical Care Medicine (SCCM), proposes a conference series led by international and multidisciplinary experts to develop pediatric critical care blood management consensus for clinical guidance and future research efforts. This group will create a comprehensive series of consensus statements via an organized and structured process over 18 months to outline existing data and future research foci in the area of plasma and platelet transfusions in critically ill children. TAXI-CAB has obtained agreements of participation from a diverse group of 25 experts in the field from five countries representing eight pediatric sub-specialties. The consensus statements will include specific strategies for adaptive dissemination and implementation into various clinical and research environments. In addition, the TAXI-CAB process, modeled after the highly successful TAXI program which developed guidelines for red blood cell transfusion in critically ill children, has been endorsed by six international organizations who are committed to the broad dissemination of the consensus recommendations. TAXI-CAB seeks to develop evidence-based guidance for pediatric intensivists to encourage the use of plasma and platelet transfusions in the right scenarios to maximize their clinical benefit and minimize their harm.

Public health relevance
PROJECT NARRATIVE Critically ill children frequently receive plasma and platelet transfusions without clear guidelines available to direct the decisions of pediatric intensivists. Mounting evidence has demonstrated significant morbidity and mortality associated with these transfusions. The Transfusion and Anemia eXpert Initiative – Control/Avoidance of Bleeding (TAXI-CAB) in collaboration with the Pediatric Critical Care Blood Research Network (BloodNet), the Pediatric Acute Lung Injury and Sepsis Investigators (PALISI), the Society for the Advancement of Blood Management (SABM), the Network for the Advancement of blood management, Haemostasis and Thrombosis (NATA), the International Society of Blood Transfusions (ISBT) and the Society for Critical Care Medicine (SCCM), proposes a conference series led by international and multidisciplinary experts to develop pediatric critical care blood management consensus for clinical guidance and future research efforts.